Impact of Regulatory T Cells on Host Susceptibility to Pseudomonas Aeruginosa Infection

PROJECT SUMMARY
Regulatory T cells (Tregs) are a subset of CD4+ T lymphocytes that control inflammatory signaling in
mucosal tissues. Tregs mitigate the release of pro-oxidant molecules by leukocytes, which protects the affected
organ from self-inflammatory damage. One of the major mechanisms by which Tregs suppress host inflammation
is via producing the nucleoside adenosine, which is generated by the ectonucleotidase CD73. In individuals
lacking either Tregs or CD73 signaling, such as those suffering from certain autoimmune pathologies, there is
substantial tissue destruction by effector leukocytes, confirming the clinical relevance of these pathways.
However, the role of Tregs in other inflammatory settings, such as bacterial pneumonia, is poorly understood.
Here, we present with strong preliminary data indicating that Tregs protect from pulmonary infection by
Pseudomonas aeruginosa, which is a prominent human pathogen that thrives in inflamed mucosae. The
mechanism by which P. aeruginosa persists in inflamed tissues is via production of biofilms in response to
oxidative metabolites released by leukocytic cells. We postulated that the mechanism by which Tregs restrict P.
aeruginosa pneumonia is through limitation of airway metabolites that fuel pathogen survival. In Aim 1 of this
proposal, we will evaluate whether Tregs protect from P. aeruginosa pneumonia by altering the airway
metabolome composition, reducing accumulation of metabolites that drive bacterial both biofilm lifestyle and
growth. In Aim 2, we will assess whether this regulation is promoted by adenosine signaling, particularly through
CD73 expression in Tregs. The findings of this project will reveal a new pathway, Tregs, as a new potential target
to control intractable P. aeruginosa lung disease.

Public health relevance
PROJECT NARRATIVE Regulatory T cells (Tregs) are a discrete subset of CD4+ T lymphocytes that protect mucosal tissues by suppressing excessive inflammation. However, the role of Tregs in bacterial pneumonia is poorly understood. Here, we will evaluate how Tregs control the pulmonary pathology caused by the major human pathogen Pseudomonas aeruginosa.